Bioequivalence of Topical Products: Elucidating the Thermodynamic and Functional Characteristics of Compositionally Different Topical Formulations

Abstract
The general requirements for generics to be considered are that the product is off-patent, contains an active
ingredient in a previously approved medicine and is shown to be bioequivalent to that previously approved
medicine. The fundamental forces governing the effects of topical drugs applied to the skin can be summed
up in three distinct dimensions. 1. The interaction of the active pharmaceutical ingredient (API) with the
excipients (formulation factors, solubility), 2. API with the skin (thermodynamic and pharmacodynamic
activity) and 3. Excipient with the skin (penetration enhancement, diffusivity, irritancy). A thoughtful
appreciation followed by a thorough understanding and then careful deliberations can help mitigate a number
of failure modes that can arise from these three dimensions and result in disapproval of generic drug
applications. However, there is an elusive fourth dimension, the psychorheology or the sensory/perceptive
judgement of the rheological properties (and other organoleptic properties) that dictates the end
user/consumers final acceptance of the product. Through this project we aim to develop meaningful risk
mitigating methods and their scientific basis. These will encompass considering product behaviour during
various stages of development/manufacturing, all the way to looking at the metamorphosing product as it is
being applied to the treatment site on the skin. The development of generic topical products has been
hampered by factors such as expensive clinical trials for BE assessment and application costs which get
blown out due to the case by case assessment of applications. A burdensome application package is
generally needed that wastes valuable resources and time on both sides of the coin. This project will ensure
the much needed theoretical and practical framework that can enable a thorough yet efficient assessment of
topical generic product applications.

Public health relevance
Narrative Generics are being prescribed heavily in some countries in place of the reference products, resulting in decreased costs of quality topical medications. However, they do not enjoy the universal support from prescribers and consumers that is usually seen for the reference listed drugs This project aims to meet the urgent need for research that encompasses product quality and performance attributes, allowing the assessment of compositionally dissimilar topical products thereby providing the tools, education and awareness that can make quality affordable generic medications available to the public.